Mechanisms of prenatal opioid exposure on brain and behavior

ABSTRACT
Opioid overdose deaths and the development of opioid use disorder (OUD) associated with the rise in
problematic opioid use patterns have reached crisis levels in the United States. Pregnant women with OUD often
undergo medication for OUD (MOUD) with methadone or buprenorphine (BUP) to reduce the severe health
effects of OUD in mothers and their newborns. However, there is increasing evidence that maternal opioid
treatment is associated with developmental defects that aberrantly affect offspring brain and behavior. Yet, the
underlying mechanisms remain largely unknown. Maternal opioid exposure may influence early lineage and fate
decisions for neurons and glia in the central nervous system by acting on opioid receptors expressed on neural
stem progenitor cells (NSPCs), but knowledge gaps exist in this regard. We hypothesize that maternal opioid
exposure with BUP management alters embryonic neurogenesis, which leads to aberrant development of the
mesocortical dopamine pathway, causing attention deficit hyperactivity disorder (ADHD)-like behavioral
sequelae in a sex-dependent manner. This hypothesis will be tested in a novel murine model of maternal opioid
exposure that mimics the standard of care for medication management of OUD. Three specific aims are
proposed: 1) determine cellular mechanisms underlying maternal opioid-induced abnormal brain development
in offspring, 2) determine the relationship between opioid-altered mesocortical development and aberrant
behavior in offspring, and 3) determine molecular mechanisms underlying effects of maternal opioid exposure
on embryonic NSPC function. This integrative study employs biochemical, genetic, and pharmacological
manipulations in both in vitro cell and in vivo animal models; and the outcomes will be evaluated by molecular,
cellular, neuroanatomical and behavioral analyses. Deciphering mechanisms underlying the impact of maternal
opioid exposure on NSPCs, brain structure and behavior will advance our knowledge of maternal opioid
exposure on brain and behavior abnormalities of offspring and pave the way toward identification of innovative
targets for the development of new treatments or preventive strategies to combat the health effects of opioids
during pregnancy.

Public health relevance
PROJECT NARRATIVE The proposed project is to study the mechanisms of maternal opioid exposure-associated aberrant brain development and behavioral anomalies in offspring. The outcomes of this study will pave the way toward identification of innovative targets for the development of new treatments or preventive strategies to combat the health effects of opioids during pregnancy.